4D CT Imaging for Improved Diagnosis and Treatment of Wrist Ligament Injuries

PROJECT SUMMARY/ABSTRACT The wrist joint permits complex motion of the upper extremity that is crucial for both precision and power movements during daily activities; therefore, wrist injuries which result in osteoarthritis (OA) come at a significant socioeconomic cost due to time off work, surgical fees and associated morbidity. Injury to the scapholunate interosseus ligament (SLIL), which connects the scaphoid and lunate bones in the proximal carpal row, is one of the most important and common upper extremity injuries. Accurate diagnosis of the location of SLIL injuries is crucial for providing the most effective treatments so that the location of the tear can be considered in a tailored treatment plan. Further, unsuccessful surgical reconstructions occur up to 20%- 30% of the time, with patients often developing OA. Current diagnostic approaches for SLIL injury include magnetic resonance imaging, which lacks the specificity to assess injury location, and wrist arthroscopy, which is invasive and results in an injury grade that is subjective and prone to interobserver variability. Thus, there is a critical need for an accurate, noninvasive, quantitative method for assessing SLIL injury location and treatment outcomes; our novel, dynamic computed tomography (CT) imaging technique will fill this gap. Our high spatial and temporal resolution 4D (3D + time) CT technique (4DCT) enables accurate quantification of key metrics during wrist motion in patients with SLIL injury. This imaging approach, which has been rigorously validated and is based on strong scientific premise, will improve clinical practice by replacing invasive and inaccurate diagnostic tests and providing a means of quantifying outcomes of surgical repairs. In this project, we propose to: establish the relationship between SLIL injury and 4DCT metrics in vitro (Aim 1); assess whether the location of SLIL injury in patients can be predicted using 4DCT metrics (Aim 2); and determine whether targeted treatment of ligament injury improves post-surgical outcomes (Aim 3). The innovation of this project is the use of rigorously validated, dynamic, noninvasive 4DCT metrics to meet the critical need to provide evidence-based information for the diagnosis and treatment of SLIL injury. The significance lies in the accurate diagnosis of SLIL injuries that will lead to optimal treatment approaches, resulting in prevention of OA due to injury or incorrect repair.

Public health relevance
PROJECT NARRATIVE Computed tomography (CT, or CAT scan) will be used to take highly-detailed and accurate pictures of the wrist joint while the patient is moving the joint. Distances between bones can be measured from the images. We will use these measurements to help diagnose wrist injuries and evaluate surgical outcomes for patients with hard to diagnose wrist injuries that can lead to pain, arthritis or crippling deformities if left untreated.